Therapy of Movement Disorders

In the area of dystonia treatment, we continue to provide botulinum toxin injections to our patients while training physicians to perform these injections. We have recently completed a study comparing electrophysiologic and ultrasound guidance for injections that shows that patients prefer the latter although the efficacy is similar (NCT02326818). Past studies from our group have shown that certain rehabilitation techniques, such as motor training and sensory training can be therapeutic. We have also been developing a new scale for severity of writer's cramp to help in the analysis of clinical trials. Another protocol (being managed from the Parkinson Clinic) is ongoing for Deep Brain Stimulation (DBS) for focal hand dystonia. New treatments are needed for essential tremor. We are looking at the possible utility and mechanism of peripheral stimulation for the treatment of essential tremor (being managed from the Parkinson Clinic). We have completed and published a successful pilot study of non-invasive brain stimulation for functional movement disorders (NCT03263013). The technique inhibits the overactivity of the amygdala by stimulation of an area of the dorsolateral prefrontal cortex that connects to the amygdala. A double-blind controlled trial is being prepared to follow-up this exciting observation.